Sample Core

PROJECT SUMMARY SAMPLE CORE
The main function of the Sample Core is to provide Research Projects 1 and 2, and the Technology Development
Project with human specimens to support the proposed research of this CCHI. The Core will manage the
collection of coded, appropriately consented tissue samples and their distribution. The Core will critically intersect
all Projects and Cores of the JAX-ISMMS CCHI program; as such, it will be an integral part of the program in the
execution of the proposed research, as well as in the provision of ongoing sample and data management
throughout the life of each Project. The Core will: 1) serve as a central resource for CCHI investigators to obtain
appropriate lung, blood, bone marrow, microbiome (oral and nasopharyngeal samples for future follow-up
studies) and associated demographic data for research purposes; 2) ensure that samples were acquired
consistent with all applicable regulations for the use of human tissues in research, including human subjects
consent; and 3) ensure that all specimens and associated information generated by each Project will be
systematically cataloged, tracked, and stored. The Core will also generate and distribute air-liquid interface (ALI)
cultures for experiments. The Core will draw on the extensive expertise of the Core Leader, Dr. Karolina Palucka,
and her team in sample procurement and management; on the sample storage and data management
infrastructure at The Jackson Laboratory for Genomic Medicine; and on the robust collaborations established
with the CCHI's clinical partners at the Hartford HealthCare Cancer Institute at Hartford Hospital (Andrew Salner,
M.D., and Peter Yu, M.D.), Nationwide Children's Hospital (Mark Peeples, Ph.D.), and Benaroya Research
Institute (Carmen Mikacenic, M.D.). The Specific Aims of the Sample Core are: Aim 1: Oversee sample
collection, acquisition, and processing; Aim 2: Manage sample storage, tracking, and distribution; Aim 3:
Generate and distribute ALI cultures; and Aim 4: Oversee personnel training and compliance.